Complement C1q and sepsis associated fatalities

1
Complement C1q and sepsis associated fatalities
Sepsis is a life-threatening systemic inflammatory condition with dysregulated host responses to
an infection. Although key hyperinflammation-based organ dysfunctions that drive disease
pathology have been discovered, the syndrome is often difficult to recognize, and current
published prognostic criteria poorly identify those destined to die with the condition. Continued
failure of our efforts in improving disease prognosis in sepsis is mainly due to substantial
heterogeneity in the patient response. Even with similar age, sex, and medical comorbidities,
there is a substantial heterogeneity in the patient mortality despite excellent supportive efforts.
Here, (1) we discovered that a subpopulation of CD49c+ neutrophil arising in critically ill patients
independently predicts mortality from sepsis. (2) We further found that the neutrophil
subpopulation associated with septic fatality dramatically upregulated gene expression of the
complement component C1q. (3) Importantly, neutrophils from septic survivors expressed higher
levels of C1q protein, while deceased patients failed to maintain C1q expression in their
neutrophils. (4) In mouse sepsis models, blocking C1q with neutralizing antibodies or conditionally
knocking out C1q in neutrophils led to a significant increase in septic mortality. (5) Treatment of
septic mice with C1q drastically increased the survival. Based on these preliminary observations,
our overarching hypothesis is that neutrophil C1q is a reliable prognostic biomarker of septic
mortality. It is hypothesized further that apoptotic neutrophils release C1q to control their
own clearance in critically injured organs during sepsis. Thus, C1q is a druggable target
for attenuation of inflammatory damage to septic patients with resulting improvement in
survival. In Aim 1, we will determine the correlation between C1q expression in peripheral blood
neutrophils and sepsis mortality in ICU patients. Aim 2 will investigate the mechanisms by which
C1q regulates the resolution of sepsis, including C1q-dependent phagocytosis of apoptotic
neutrophils and differentiation of macrophages. Aim 3 will investigate mechanisms underlying the
heterogenous C1q expression. Aim 4 will determine the effects of recombinant C1q and its mutant
variants on the survival of septic mice. Taken together, this proposal addresses mechanisms
regarding how the dysregulated host response threatens patient survival and offers a molecular
target for dampening the destructive arms of the hyperinflammatory response while promoting
disease resolution and tissue recovery.

Public health relevance
Severe sepsis, defined as sepsis associated with acute organ dysfunction, is an increasing cause of morbidity and mortality among children and adults, and has been one of the most significant challenges in critical care. This study will determine the underlying mechanisms that lead to the accumulation of neutrophils in the organs that causes fatal hyper-inflammatory responses in septic patients. Understanding how to control tissue damage through manipulation of neutrophil resolution has potential applications in many acute/chronic inflammatory settings including sepsis.